EFFECT OF ALBUTEROL ON PULMONARY MECHANICS IN INFANTS

To test the hypothesis that albuterol is effective in improving pulmonary mechanics in neonates with bronchopulmonary dysplasia and that this response may be achieved without significant tachycardia as a side effect of therapy.